Core B Data Management and Analysis (DMAC)

ABSTRACT
The unifying theme/goal of this P42 Superfund application is to develop a problem-focused (environmental lung
injury secondary to heavy metal exposure), solution-oriented (biomarker discovery and therapeutic target
identification in humans; mitigation/remediation in the air and soil) and integrated (bringing together biomedical
scientists, engineers, ecologists, and social scientists) research plan. In order to achieve this goal, the UAB-SRP is
comprised of five research projects and five Cores. These research projects have inherently complex data
management and data analysis needs, in addition to the rigorous study design and data collection methodologies
required by biomedical and human studies. The Data Management and Analysis Core (DMAC) provides centralized
data management support for the research projects of the UAB-SRP and biostatistics support as well as data
integration and collaborative research. The DMAC supports the UAB-SRP by providing database management that is
in compliance with NIH regulations and innovative statistical support via seamless consultation. Through collaboration
and consultation, the DMAC will provide UAB-SRP investigators with assistance and direction in their experimental
design, data collection, data management, and interim and final statistical data analyses. The DMAC will lead the
effort to design a biomedical and basic science research database with a user-friendly interface for data entry, data
retrieval, and patient or sample tracking following the FAIR guiding principles for scientific data management and
stewardship as well as data integration. We will also develop procedures to ensure data quality, integrity,
confidentiality, and data sharing.
The DMAC will be integrated into the UAB-SRP research projects, including the trainees, from study inception through
data collection, data management, data integration, and analysis. Their close partnership with the Project Leaders at
UAB will help ensure the research projects have proper biostatistics and data management support, are using
appropriate and novel methods, and the study findings are correctly interpreted in scientific publications.

Public health relevance
PROJECT NARRATIVE The Data Management and Analysis Core (DMAC) provides centralized biostatistics as well as collaborative research and data management support for the research projects of the University of Alabama at Birmingham (UAB) Superfund Research Program (UAB-SRP). Through collaboration and consultation, the DMAC will provide UAB-SRP investigators with assistance and direction in their experimental design, data collection, data management, and interim and final statistical data analysis. The DMAC will lead the data integration and serve as the focal point from which UAB-SRP investigators and trainees, including basic scientists, biomedical researchers, and clinicians, can draw data management and statistical expertise for the communication and analysis of their research projects.